Chromatically Orthogonal Photolabile Protecting Groups for the Parallel On-Chip Synthesis of High-Density Glycan Microarrays

Abstract. The objective of this research is to identify carbohydrate-compatible photolabile protecting groups
and light sources to facilitate the parallel on-surface synthesis of high-density glycan microarrays—e.g. glycan
chips—in a manner similar to the synthesis of gene chips. Instead of using monochromatic light and a single
photolabile protecting group to spatially control the extension of a linear polymer (DNA) on the microchip, as in
gene chip manufacture, irradiation with different wavelengths of light combined with wavelength-selective tem-
porary protecting groups will allow for constructing complex, branched glycans on a microchip surface. I aim to:
(1) identify carbohydrate-compatible photolabile protecting groups and optimal light sources to pair with each;
and (2) identify a pair of wavelength-selective (`chromatically orthogonal') protecting groups and demonstrate
their use in branched glycan synthesis, paving the way towards the parallel on-chip synthesis of high-density
glycan microarrays. Wavelength-selective photochemistry will be achieved by separating the absorptions of pho-
tolabile protecting groups to allow for selective excitation. Such high-density combinatorially-synthesized glycan
chips are expected to permit rapid epitope mapping and screening of the selectivity of glycan binding partners.
For example, exposing a dye-labeled lectin, antibody, or virus/bacteria/pathogen binding protein to the chip will
allow its binding specificity for numerous glycan structures to be determined from a single experiment. The ability
to synthesize high-density combinatorial libraries of carbohydrates will aid in resolving the structure-function
relationships of carbohydrates, help to understand the target epitopes of glycan binding partners, and accelerate
efforts to uncover the structure and function of the glycome.

Public health relevance
Narrative. This work develops new methods for the combinatorial synthesis of glycan microarrays. Because glycans are involved in numerous biological processes such as cellular trafficking, signaling, cancer metastasis, viral entry, and immune defense, etc., such a technological breakthrough will have immediate impact on human health by helping to understand the target epitopes of glycan binding partners, and accelerate efforts to uncover the structure and function of the glycome.